Uncovering the Mechanisms that Promote and Maintain Germ Cell Identity

Project Summary/Abstract
Germ cells have the potential to generate every cell type in the body. Specified in the embryo, germ cells face
the challenge of protecting and maintaining this poised totipotency for the entirety of an organism’s reproductive
lifespan. Despite the fundamental importance of this protection for the fertility and health of the next generation,
the molecular programs that promote and protect germ cell identity are poorly understood. A specific program
for germ cell transcriptional activation has yet to be described, largely because a ‘master regulator transcription
factor’ for germ cell fate has not been identified in any organism. Instead, primordial germ cells (PGCs) rely on
conserved networks of RNA regulators that repress somatic differentiation programs and protect the germline
genetic program, a strategy that is common to PGCs of worms, flies, mice, and humans. Yet how these RNA
regulators intersect with the gene regulatory network of PGCs is unknown. My proposed research program seeks
to uncover the molecular mechanisms that initiate and maintain germ cell identity by revealing the PGC gene
regulatory network. The goal of the research proposed here is to (a) uncover mechanisms that ‘repress’ the
somatic program thereby allowing the PGC program to develop and (b) identify the ‘instructive’ cues that actively
control PGC fate. In Aim 1, I focus on discovering the dynamics of germline gene activation during
embryogenesis by identifying specific, temporally regulated sets of genes that define the PGC transcriptional
program using single-cell RNA sequencing. Using tissue-specific interference, I will distinguish between cell-
intrinsic and non-autonomous signaling mechanisms regulating the PGC transcriptional program. In Aim 2, I will
probe the ‘instructive’ cues of germ cell identity by uncovering PGC-specific cis-regulatory sequences using
ATAC-seq. I will identify transcriptional regulators (such as transcription factors/chromatin factors) that bind these
cis-regulatory sequences and test their role in the PGC transcriptional program. In Aim 3, I address the
‘repressive’ model by examining the function of a critical regulator of germ cell fate, the conserved RNA-binding
protein Nanos. Using the RNA target identification method HyperTRIBE, I will identify Nanos targets and ask
whether these targets promote the germline program and/or repress somatic programs. I will use Drosophila as
my model system, expanding my prior training in biochemistry and molecular biology to encompass organismal
biology, development, and genetics and gaining expertise in bioinformatics and gene regulation. Together, this
work will uncover the regulatory landscape of primordial germ cells, providing a fundamental understanding of
the mechanisms that specify germ cell fate, promote fertility, and ultimately protect the survival of the species.

Public health relevance
Project Narrative Germ cells must maintain their identity for the entirety of a species reproductive lifespan, a task that can last more than forty years in humans. This unique challenge raises the question: What underlying molecular processes govern germ cell identity and protect germ cells from reprogramming towards a somatic cell fate? Using the fruit fly Drosophila melanogaster, I will answer this fundamental question by (i) characterizing the germline transcriptional program and probing cell autonomous vs nonautonomous mechanisms for transcriptional activation (ii) identifying regulatory factors that are instructive for germline specification, (iii) uncovering how the conserved translational repressor Nanos protects germ cell fate by repressing somatic transcription in germlines from flies to humans.